The Adherence Promotion with Person-centered Technology (APPT) Project: Promoting Adherence to Enhance the Early Detection and Treatment of Cognitive Decline

Black scientists are underrepresented in health-related research fields and women from racial and ethnic minority groups face particular challenges at the graduate level and beyond. The goal of this supplement, consistent with the priorities of NIH, is to address this gap and promote diversity in behavioral and biomedical health research by providing support for Ibukun E. Fowe, a Public Health PhD student in the department of Health Systems and Policy at the OHSU-PSU School of Public Health and member of an underrepresented group in health-related sciences, to gain experience conducting research in the area of understanding older adults’ adherence to technology-based interventions to measure and support health behaviors, including behaviors that predict or prevent cognitive impairment. This support is aimed to aid Fowe transition from graduate student to post-doctoral researcher and gain background and research experience to help ensure her success as an independent investigator. She will gain experience supervising and participating in the implementation of complex randomized controlled trials, an understanding of the potential of machine learning techniques to detect and prevent cognitive impairment, and additional training through supplemental activities developing and conducting studies that will explore barriers to the collection and use of older adults’ digital phenotypic and biomarker information through wearable devices and smartphone applications. This will serve the parent grant by expanding the impact of each specific aim (SA); SA1) enhancing adherence to cognitive intervention and assessment protocols - digital phenotypic and biomarker information provide useful state and trait information about individuals which can enhance predictions of adherence failures, SA2) improving understanding of barriers to long-term adherence ?the study of barriers to long- term adherence will be extended to technologies beyond tablet and smartphone assessments and interventions through supplemental activities involving wearables, and SA3) assisting in the development of algorithms for predicting and preventing adherence failures ?Fowe, working with the data and computer scientists of the APPT team, will investigate how digital phenotypic and biomarker information might provide additional context to enhance predictions of adherence lapses and improve the timing of reminders to maximize successful intervention reengagement. We have developed a tailored plan for Ibukun Fowe’s research and career development. This plan includes 1) supervised mentoring and mentorship sessions; 2) active involvement in the research design and analysis process; 3) active involvement in the dissemination of study findings; 4) interactions with other researchers and scientists, and 5) networking through the process of participation in scientific activities such as professional meetings, conferences, and research meetings.

Public health relevance
This supplement is designed to provide Ibukun Fowe, a dedicated and promising junior investigator and member of an underrepresented group in health-related sciences, with the experience and mentorship necessary to conduct aging research with a specific focus on cognitive health and decline, and to gain understanding of the potential of artificial intelligence and other machine learning approaches to advance successful aging. The diverse expertise within the APPT team of the parent grant is well-suited to provide relevant mentorship and training to help Fowe transition to a successful independent investigator.